Brain-Wide Genome Editing Enabled by Intravenously Administered Non-Viral Nanovectors As a Potential Therapy for Alzheimer’s Disease

Project Summary
Currently, there is no effective way to slow down the progress of Alzheimer’s disease (AD) or prevent it. CRISPR
genome editing is a revolutionary and versatile genetic engineering technique, making it possible to treat the
root causes of genetic neurodegenerative diseases (NDDs) such as AD. However, the promise of brain gene
therapy relies on the efficient delivery of biologics to the brain, which is extremely challenging due to the blood-
brain barrier (BBB). To date, in vivo brain gene therapy has mostly been achieved using viral vectors that require
laborious customization and have troublesome safety profiles. Non-viral vectors are largely administered via
intracranial administration, which is invasive and can only enable gene therapy in a small and localized brain
region. Similar to other NDDs, AD affects multiple brain regions. Thus, there is an urgent need to develop efficient
non-viral delivery vehicles capable of bypassing the BBB for safe and efficient brain-wide gene therapy.
The objectives of this project are (1) to engineer glutathione (GSH)-responsive silica nanocapsules (SNCs)
capable of bypassing the BBB and delivering CRISPR genome editors to the whole brain systemically, and (2)
to evaluate the therapeutic efficacy and biosafety of brain-wide genome editing enabled by the optimized SNC
for the treatment of AD using a novel amyloid precursor protein (APP) knock-in AD mouse model and a unique
gene target for APP modulation. The unique SNC possess a long list of desirable properties including versatile
payload types, versatile surface chemistry for ligand conjugation, high payload loading content and efficiency,
small particle sizes, excellent in vivo stability, good biocompatibility, and scalable production. Our preliminary
data has shown that intravenously administered SNCs can efficiently deliver mRNA, DNA, Cas9 mRNA/sgRNA,
and Cas9/gRNA ribonucleoprotein (RNP) to the whole brain of healthy mice with intact BBB.
We aim to further optimize the amounts of the dual brain-targeting ligands (i.e., glucose and rabies virus
glycoprotein (RVG) peptide) and dosages of the SNCs for enhanced brain-wide systemic delivery of two types
of CRISPR genome editors (i.e., (1) Cas9 mRNA/sgRNA, and (2) plasmid DNA with a neuron-specific human
synapsin 1 (SYN1) promoter and expressing both Cas9 and sgRNA). We will further determine their therapeutic
efficacy and biosafety in treating AD using a novel APP knock-in AD mouse model while employing a unique
gene target for APP modulation. The gene editing efficiency and biosafety profiles of the SNC, and the
pathological and behavior changes of the AD mice will be monitored by various techniques including a novel
serial two-photon tomography whole-brain amyloid imaging platform. With promising initial studies, the best-
performing SNC will be submitted to the Preclinical Testing Core of the NIA-sponsored STOP-AD program for
comprehensive preclinical evaluation. This project will pave the road for a new, safe, non-invasive and effective
therapeutic approach for familial AD. Given the modularity and versatility of the SNCs, and ease of targeting
different genes by the CRISPR system, we anticipate that our SNCs will be applicable for a wide range of NDDs.

Public health relevance
Project Narrative Currently, there is no effective way to slow down the progress of Alzheimer’s disease (AD) or prevent it. CRISPR genome editing is a revolutionary and versatile genetic engineering technique, making it possible to treat the root causes of genetic neurodegenerative diseases such as AD. We aim to (1) engineer a new class of stimulus- responsive silica nanocapsules capable of bypassing the blood-brain barrier and delivering CRISPR genome editors to the whole brain systemically, and (2) determine the therapeutic efficacy and biosafety of brain-wide genome editing enabled by the optimized silica nanocapsule for the treatment of AD.